An mHealth Approach to Decreasing Opioid Abuse and Other Diseases of Despair in Rural Populations

Project Summary/Abstract
Rural Americans face numerous health disparities compared to their urban counterparts and are more
likely to die from chronic health conditions, including substance abuse. Indeed, opioid-related mortality is
highest in certain rural areas of the U.S., including Appalachia, New England, and the mountain west. A
number of studies looking at morbidity and mortality provide insight into the health problems afflicting less
educated, rural populations.6-9,14-15 Lack of high school diploma, mental illness, alcohol use, and illicit drug use
were all substantially higher in the population of decedents, and individuals suffering from these problems are
at heightened risk for opioid misuse.22-29
The purpose of this project is to develop a mobile-based opioid prevention program for rural-based
blue-collar workers that provides robust preventive interventions aimed at reduction in alcohol consumption,
management of negative mood states including anxiety and depression, and non-pharmacologic approaches
to managing pain. The program aims to fill an important gap in service provision to rural adults at risk for opioid
misuse. The program will capitalize on technologies available in rural communities – namely mobile health –
and will be media rich, including a program ‘coach’ and videos of individuals that users can relate to describing
their experiences dealing with pain, substance use difficulties, stress and mood issues - and the impact of
these issues on their lives. Similar to other health promotion and substance abuse prevention programs
developed by our group, the program will be highly individualized - tailored by user characteristics and
experiences, directing users to management of difficult moods, techniques in the self-management of pain, and
avoidance of abusing alcohol and other substances, including opioids.
In Phase I, with crucial input from two focus groups and our expert consultants, ISA staff will develop
and pilot test a mobile opioid misuse prevention program embedded within a larger health promotion program.
Pre-development focus groups will be conducted with individuals who will be recruited to help shape the
structure and content of the program. ISA staff and the Redmon Group will develop the prototype program,
fully developing the Introduction, and extensive sections of My Health Profile, Understanding and Managing
Moods, and Taking Care of Yourself – Never Give Up! for Phase I. Following development and expert review
of the prototype program, 20 end users will be asked to pilot test the program, including a usability test,
quantitative rating of the program, and interview about their experience using the program. To advance to
Phase II, there must be an 80% error-free rate and quantitative ratings must be 4 or higher for all items.

Public health relevance
Project Narrative This project aims to develop a web-based program optimized for use on a smartphone focusing on management of negative affect, pain, and prevention of alcohol and other substance abuse, including opioids, among rural, blue-collar, working-age adults. The program will deliver custom information to users following assessments of their needs and personal situation. The program will be designed to provide users with the information, skills, and tools needed to promote positive coping via management of negative emotions, self- regulation of pain, and safe consumption of alcohol and other substances. Materials will be multi-modal in format (e.g., narration, a program ‘coach’, interactive assessments with feedback, tailoring of information, and text messaging). The goal of the program will be to promote self-management and minimization of problems associated with opioid use. Upon successful completion of Phase I a Phase II application will be submitted.